Adaptive responses to overfeeding and weight regain in reduced obese individuals

Project Summary/Abstract
The persistent problem of weight regain following weight loss is perhaps the most significant barrier to
addressing the current obesity epidemic. The biological drive to regain weight following weight loss is due in
part to increased appetite leading to increased energy intake (EI) and reductions in energy expenditure (EE) in
part due to changes in energy expended in physical activity (PA). These physiological adaptations to weight
loss are most relevant during episodes of dietary indiscretion resulting in overfeeding (OF) when reduced
obese (RO) people fail to respond to the state of positive energy balance in a way that maintains the reduced
state. There is increasing evidence that RO individuals who exercise (RO-Ex) are less likely to regain as
compared to RO individuals who are sedentary (RO-Sed). We conducted studies on the effects of OF on EI,
EE, PA and fat metabolism in non-obese individuals either prone (OP) or resistant to obesity (OR). Subjects
were then followed for 5 years to measure weight change. These studies showed that differences in the
response of nocturnal fat oxidation and higher levels of moderate/vigorous PA following OF correlated with 5
year weight gain suggesting that these factors were potentially important mechanisms for weight gain. Further
we have shown that measures of hunger fail to suppress with OF in RO individuals and that nocturnal fat
oxidation is reduced in RO-Sed but maintained in RO-Ex following a day that included a bout of exercise. We
now propose to study the responses of EE, EI, PA and fat metabolism to OF (40% above basal energy for 3
days) in obese, RO-Sed and RO-Ex men and women and correlate these responses to weight change over the
subsequent year. We hypothesize that changes in the response of one or more of these variables to OF will
correlate with weight regain. The Significance of the studies lies in the fact that they will begin to clarify the
metabolic mechanisms that underlie a propensity for weight regain in RO individuals. Innovation: The
proposed studies will systematically examine a range of responses to OF and prospectively correlate them with
weight gain while taking into account aspects of behavior relevant to weight regain. We believe that these
studies will lay a foundation for future studies that will examine the mechanisms underlying specific adaptive
responses that directly relate to weight regain and help with the design of strategies to address and/or respond
to these processes.

Public health relevance
Project Narrative Weight regain following weight loss is a vexing problem for obese individuals. To more effectively address this problem we need a better understanding of the underlying biology of the weight reduced state. We recently have found that reductions in fat oxidation while people sleep are associated with a predisposition to weight gain. We now propose to perform in depth studies of appetite, energy expenditure, physical activity levels and fat metabolism in obese people and obese people who have lost weight either with diet alone or with diet plus exercise. Subjects will be studied following a period of overeating to better define how differences in the biological responses to overeating in people who have lost weight might be involved in promoting or protecting against weight regain.